Targeted Suppression of Microtubule Dynamics for Treatment of Metastatic Castration-Resistant Prostate Cancer

PROJECT SUMMARY
The goal of this proposal is to develop a targeted therapy for treatment of metastatic castration-resistant prostate
cancer (mCRPC). There is currently no cure for this disease and available therapies leave significant room for
improvement based on dismal survival rates. Prostate-specific membrane antigen (PSMA) is a clinically validated
molecular target for diagnostic and therapeutic purposes based on its significant overexpression in PCa tissue
compared to normal cells. Glutamate-ureido-based small molecules have exceptional affinity for PSMA and have
been labeled with radionuclides to enable targeted tumor detection and therapy. The small molecule 177Lu-
PSMA-617 (cytotoxic beta radiation emitter) recently gained FDA-approval for PSMA-targeted radioligand
therapy (RLT) of mCRPC. However, despite its initial antitumor activity, disease progression following 177Lu-
PSMA-617 RLT occurs in virtually all patients and led to the development of the more potent RLT agent 225Ac-
PSMA-617, where the alpha-emitting radionuclide 225Ac provides stronger DNA damaging capabilities. Although
recent clinical data with 225Ac-PSMA-617 showed favorable responses, disease progression was still observed.
Furthermore, non-tumor binding of 225Ac-PSMA-617 causes considerable damage to the salivary glands and
leads to life-long xerostomia in a large percentage of patients. Since PSMA expression often remains actionable
as a tumor target following RLT, the development of a non-radioactive targeted therapy could extend the
therapeutic benefits of PSMA targeting without the associated risk of organ irradiation. Given the absence of a
validated PSMA-targeted drug conjugate, we used PSMA-617 as the foundation for a drug conjugate containing
the microtubule inhibitor monomethyl auristatin E (MMAE) and a custom macrocyclic linker known as MMC
(multimodality chelator) to enable direct radiolabeling for imaging and quantitative analyses. We provide strong
preliminary evidence of PSMA-mediated uptake with the drug conjugate in cells and tumor models, while also
revealing remarkably fast elimination from blood and normal organs, including the salivary glands. Based on
mounting clinical evidence of MMAE-related resistance, we identified cryptophycin, a microtubule inhibitor with
1-2 fold higher potency than MMAE in castration-resistant prostate cancers cells, as the preferred payload for
drug conjugate development. We seek to build on these findings and propose the following specific aims: (1) to
synthesize a PSMA-drug conjugate for selective delivery of cryptophycin, (2) to visualize and quantify the in vivo
targeting properties of PSMA-mediated cryptophycin delivery in tumor models, and (3) to demonstrate in vivo
efficacy and safety. To accomplish our aims, we have formed a strong investigative team with complementary
expertise in basic, translational, and clinical theranostics. Successful completion of our aims will demonstrate
the feasibility of treating mCRPC with a PSMA-targeted drug conjugate and could address an emerging
treatment gap for patients that may not be eligible for additional PSMA-targeted treatment.

Public health relevance
PROJECT NARRATIVE Despite a growing therapeutic toolkit, durable responses are rare in metastatic castration-resistant prostate cancer. The goal of this project is to develop a biomarker-based targeting strategy that will deliver an exceptionally potent chemotherapy agent to tumors. This research is highly relevant to public health because it has the potential to extend the therapeutic effects of standard-of-care therapies and improve clinical outcomes.